Innate Immune Signal Transduction Specificity in Inflammatory Disease

ABSTRACT
The NOD2:RIPK2 complex helps a cell recognize and respond to an intracellular bacterial infection. Activation
of this pathway initiates a cytokine response that helps tailor the adaptive immune system to eradicate the
offending pathogen. Signaling from this complex must be precisely tailored. Too little inflammation can cause
immunodeficiency that can manifest in dysbiosis while too much inflammation can manifest in inflammatory
disease. Over the past decade, my lab has worked to understand this signaling system with the goal of
identifying drug targets such that when the NOD2:RIPK2 complex is hyperactive and therefore
hyperinflammatory, we have pharmacologic tools to inhibit it. To this end, we have now developed agents for
RIPK2 that inhibit its kinase activity. These inhibitors are now at the Pre-IND stage and we anticipate filing for
an IND in late 2020 or early 2021. Despite this chemical success, key questions surrounding RIPK2’s kinase
activity remain. While some studies suggest that kinase activity is necessary for function, others suggest it is
not. We don’t know the kinase-dependent versus kinase-independent signaling pathways that are activated or
inhibited. We don’t know any bone fide RIPK2 substrates, and we don’t know which patients will particularly
benefit from RIPK2 inhibition. To this end, we have developed phosphoproteomic and phospho-substrate
databases utilizing mass spectrometry and chemical genetics. This grant application aims to leverage these
unpublished databases to i) identify novel RIPK2 substrates, ii) identify novel RIPK2 kinase-regulated signaling
pathways and iii) identify patient populations in which RIPK2 targeting might be most efficacious. Better
understanding RIPK2’s kinase activity is highly significant as RIPK2 inhibitors enter the clinic over the next few
years.

Public health relevance
LAY SUMMARY Overactivation of the inflammatory response underlies a multitude of inflammatory diseases, and the Abbott lab attempts to identify novel proteins that can be targeted pharmaceutically to halt these diseases. To this end, we have identified small molecule inhibitors of the kinase, RIPK2, a key inflammatory kinase. The current application aims to extend this work by studying the kinase activity of RIPK2. Which proteins does it phosphorylate? Which signaling pathways does it influence, and can we identify clinical scenarios in which its inhibition would help ameliorate disease? Answers to these questions are important as our RIPK2 inhibitors move into patients.